Mechanisms of Resistance to mTOR Targeted Therapies

The broad objective of this proposal is to investigate the intrinsic mechanisms of tumor
cell resistance to newly developed mTOR inhibitors such that their future use may be optimized
in the clinic. We have identified an alternate mechanism of mRNA translation initiation that is
activated upon mTOR inhibitor exposure allowing tumor cell survival in the face of global
inhibition of protein synthesis. These experiments will delineate the molecular mechanisms
promoting activation of this salvage pathway and will pre-clinically evaluate the repurposing of
an FDA-approved drug as a small molecule inhibitor targeting this pathway for synergistic
antitumor effects in combination with mTOR inhibitors. We will utilize a combination of genetic
and biochemical approaches to address the mechanisms by which the salvage protein
synthesis pathway is activated in TOR inhibitor resistant brain and breast cancers. We will
utilize mouse models of these diseases to evaluate the efficacy of these inhibitors.

Public health relevance
TOR kinase inhibitors are novel drugs with exciting and impressive antitumor activity in preclinical studies. It would thus, be critical to understand the mechanisms by which tumor cells respond to these agents such that they can be used most effectively used in the clinic. This proposal seeks to understand the mechanisms of tumor cell resistance to mTOR inhibitors and evaluate novel targeted therapies in combination with mTOR inhibition. These studies may benefit both Veteran and non-Veteran populations and provide additional future treatment options. Brain and breast cancers are relatively frequently encountered in our Veterans and current treatment protocols have not advanced significantly. The development of additional treatments may improve the current prognosis for patients and also find utility in the treatment of lung and prostate cancers, which are common in our Veteran population.